Training in Renal Research

Abstract
This application requests five years of continued support for our postdoctoral training program in
research relevant to the kidney. The overall goal of this program is to develop skilled
investigators trained to conduct research in clinical science, translational science or bench
science, and capable of academic careers as independent researchers. This program
represents collaboration between the University of Pennsylvania's adult and pediatric renal
divisions, and Penn's many biomedical research programs. The program is advantaged by
Penn's outstanding collaborative research environment. Our program is designed to support two
years of salary and tuition costs for five MD, MD-PhD, (or rarely PhD) post-doctoral fellows per
year, who typically have completed training in either adult or pediatric clinical nephrology. The
training program: will provide supervised, hands-on trainee-driven research experiences in
state-of-the-art scientific concepts, methodological approaches and foundational knowledge for
advancing our understanding of kidney disease; will offer a core curriculum that includes
completion of a formal master's degree program; will unite talented and successful mentors who
have active research programs relevant to pediatric and adult kidney disease; will maintain a
strong mentoring program that employs career development enhancement activities that foster
community and enable trainee career advancement; and, will maintain experienced leadership
and an administrative structure that ensures fluid program function, provides for trainee and
mentor assessment, and ensures ongoing program quality improvement.

Public health relevance
Project Narrative Kidney disease is a leading cause of suffering and death in the United States. The Penn Renal Research Training Program is intended to train post-doctoral fellows in the experimental approaches and science necessary to address these devastating problems.